Family Violence: The Role of Trauma

Project Summary/Abstract
Violence within families of young children is pervasive and has considerable adverse psychiatric, psychosocial,
cognitive, and physical health consequences for child and adult victims and witnesses. To design methods to
effectively prevent or intervene in this major public health problem, more specific and nuanced information is
needed about incidents of family violence, including what factors immediately precipitate violence and promote
its persistence within incidents of violence as well as individual differences in how such factors operate. The
first aim of this study is to describe and compare between- and within-person rates, frequencies, and severity
of incidents of parent to child violence (PCV) and intimate partner violence (IPV) as well as the trajectory by
which the severity of violence increases or decreases within the course of incidents (Aim 1). Additionally, this
study is uniquely designed to measure within-incident co-occurrence (or “spillover”) of PCV and IPV. As such,
the between- and within-person rates, frequencies, and severity of distinct patterns of violence spillover will be
described and compared to violent incidents that occur without cross-dyad spillover, then characteristics of
violence in the first family subsystem that predict the occurrence and severity of violence in a subsequent
family subsystem will be tested (Aim 2). Finally, given extensive overlap between trauma exposure and family
violence perpetration, diverse forms of trauma-related perceived threat (e.g., rejection, dominance) and
theoretically related contextual factors will be examined as immediate, incident-level precipitants of the
occurrence, persistence, and trajectory/acceleration of PCV, IPV, and spillover. To understand whether trauma
exposure and global (individual-level) threat perception are translated into immediate, incident-specific
predictors of violence, additive and moderating effects of trauma history and global threat perception on the
link between incident-level threat perception and the persistence and acceleration of PCV, IPV, and spillover
will also be tested (Aim 3). Doing so will help reconcile empirical literatures that disagree regarding the
conditions under which trauma and biased threat perception promote or inhibit violent behavior.
Using non-identifiable data collection procedures to minimize under-reporting of sensitive information, online
protocols will measure individual factors and repeated in-depth monthly telephone interviews will measure the
process and context of family violence. Because early childhood is a time of increased family stress when rates
of PCV peak and children are most likely to be involved in episodes of IPV, participants will include 200
couples (i.e., 400 individuals) with a child age 3-5 years enrolled in an urban or semi-rural Head Start program.
These procedures will increase feasibility (including recruitment of fathers/father figures) and the racial/ethnic
diversity of the sample, reduce method variance, alleviate many limitations of traditional measures family
violence, and target low-income families who are at greatest risk for family violence.

Public health relevance
Project Narrative To effectively prevent the occurrence of, and children's exposure to, family violence (i.e., intimate partner violence and parent to child violence), we must understand how often incidents of violence occur, the ways in which incidents unfold, and the extent to which violent behaviors in one family dyad directly lead (or “spillover”) to violence in another family dyad. Moreover, to direct more powerful intervention efforts, we must know which individual factors and immediate precipitants are most likely to trigger and escalate distinct forms of family violence. By ultimately preventing the occurrence of family violence, substantial adverse psychiatric, psychosocial, cognitive, and physical health consequences as well as economic costs can be averted.